DNA nanotechnology and synthetic biology for AI-supported detection and precision therapeutics

DNA nanotechnology and synthetic biology for AI-supported detection and precision therapeutics
Project Summary:
Overview and Goals: In this MIRA application, we propose to develop a transdisciplinary research program
centered around AI-supported biosensing and precision therapeutics using DNA nanotechnology and synthetic
biology. My lab at the State University of New York, University at Albany (UAlbany) is a bioanalytical and
biophysical chemistry lab focused on technology development. During my independent career, my lab has
integrated chemistry, nanotechnology, biology, and advanced computational methodologies for biomedical
investigations, i.e., (1) Highly sensitive point-of-care detection of whole and/or fragmented genomes, (2) DNA
nano-receptors for AI-enabled biomarker-free detection, (3) Controllable RNA, and small molecule nano-
therapeutics. In this MIRA proposal, we propose to build upon the expertise and discoveries accumulated
throughout my career at UAlbany to develop a robust research program.
Research Track Ia. Synthetic biology cascade reaction for paper-based pathogen detection. We propose to
develop a synthetic biology cascade reaction using an isothermal amplification reaction, CRISPR-Cas12a, a
toehold RNA switch, and in vitro translation. In this direction, we will employ the proposed cascade reaction to
detect a pathogen of interest through a color change on a paper substrate. To demonstrate our technology
against various pathogens (bacteria and viruses) and genomes (RNA and DNA), we will use circular double-
stranded DNA genomes from Salmonella and wild-type Escherichia coli and single-stranded RNA genomes from
West Nile, Zika, and Dengue viruses as model systems. Because there is more than one amplification step in
the proposed cascade reaction, the sensitivity is greater than that of conventional single-step amplification
reactions. The specificity is enhanced due to several checkpoints in the cascade reaction. The entire reaction is
complete under 6-hrs, making it highly useful for point-of-care detection of low-copy pathogens.
Research Track Ib. DL-assisted image analysis and mobile-app-driven data transmission. The visual data
obtained in Part Ia will be analyzed through deep-learning (DL) assisted image analysis in collaboration with 'AI
in Complex Systems Lab' at UAlbany. A mobile app will be developed to capture data images and analyze them
through a DL engine in a cloud database with wireless transmission capabilities. This step will facilitate the
translation of our findings into practical use for public health.
Research Track II. ML-supported DNA nano-receptor array technology for biomarker-free analysis. My lab has
been investigating the interactions between two-dimensional nanoparticles and single-stranded DNAs through
theoretical and experimental studies. Using the insightful knowledge learned through these studies, we have
formulated DNA-nanoparticle assemblies (termed ‘DNA nano-receptors’), which are the building blocks of our
proposed DNA nano-receptor array platform.
The DNA nano-receptor array generates fingerprint fluorescence data when it encounters a biosystem of interest.
Enabled by machine learning (ML), the fingerprint data is used to make predictions to identify individual targets.
We have demonstrated the detection of specific cell types, RNAs, proteins, and even complex mixtures (i.e.,
adulterants in fruit juices) using this platform without requiring a specific biomarker. In this MIRA application, we
will advance our technological platform beyond its initial phase and challenge it against complex systems such
as antibiotic resistance in bacteria, pathogen contamination in consumable products, and subtypes in breast
cancer cell lines. This innovative direction in our efforts will result in a simple and bias-free detection setup that
utilizes predictions/decisions made by ML.
Research Track III. Genome-triggered encapsulated payload release from DNA hydrogels. In this track, we
propose to develop DNA hydrogel formulations that have tunable pore sizes and stiffness. Encapsulation of small
molecule drugs, RNAs, proteins, and imaging agents will be demonstrated for advanced biomedical applications.
The mechanism of payload release will be incidental to the hydrogels’ responsiveness to a biological stimulus.
When the genome of interest is detected, the hydrogel will decompose and release its payload concurrent with
an indicative fluorescence signal. To demonstrate its application, we will use a model pathogen’s genome, which
will trigger the decomposition of the hydrogel, thereby releasing the encapsulated content. The multi-layered
encapsulation of drug molecules will facilitate a sequential release and treatment mechanism.
Summary: As a new NIH investigator, this MIRA proposal will significantly bolster my multifaceted research
program around the central theme of synthetic biology and DNA nanotechnology. This proposal outlines the
collection of projects within my lab, and if funded, it will also provide essential resources to explore new research
avenues. We anticipate the development of several AI-supported biotechnologies and precision therapeutics.
The proposed research developments are poised to address various challenges, extending beyond the model
systems described in the research approach. The impact of these developments will generate both knowledge
and tools that will benefit the broader scientific community.

Public health relevance
Project Narrative: The proposed paper-based tests will enable rapid screening of a pathogen infection through visual inspection while the mobile app-facilitated data analysis and wireless communication will prevent the risk of disease transmission through early detection. The machine-learning supported detection technology enables diagnostic through tissue analysis, however, it can be used for other public health-related challenges, i.e., detection of food-borne pathogens in consumable products. The DNA-hydrogel platform can be used as drug cargo which releases its content for treatment when the disease-causing pathogen is detected.